Power-Up Study Administrative Supplement to Promote Diversity

Plans to Enhance Candidate’s Research Capabilities
This research supplement will train Ms. Diaz in research methodology and increase her knowledge of how
neighborhood inequities influence health behaviors among residents. She will gain experience in evaluating
research of the social determinants of health including statistical techniques used in the field. The award will
place Ms. Diaz in a rich research environment where she will be exposed to other investigators doing research
at the intersection of primary care and public health. Ms. Diaz is committed to a career in the health care
professions which is evidenced by her involvement in health research pipeline programs STEP-UP as an
undergraduate student and in preparation for her next stage. The mentorship she will receive from Dr.
Chambers (and mentorship team) will place her on track for success in her future graduate work. Her
mentorship plan includes enrichment activities that will expose her to research methods in public health and
lifestyle interventions. More specifically, Ms. Diaz will (1) prepare reading lists on relevant topics to be
discussed with Dr. Chambers during their weekly meetings and journal club; (2) learn how to measure the built
environment and collect data; (3) learn about human subject protection; (4) gain training in motivational
interviewing and patient engagement; (5) complete coursework in research methods and social epidemiology;
(6) present data for scientific meetings; and (6) assist in preparation of manuscripts for publication in peer
reviewed journals.

Public health relevance
Relationship to Parent Grant There is need for research that can identify barriers and facilitators to engagement of men in health behavior studies. While some of these barriers may exist at the individual-level which studies such as Power-Up can address, other neighborhood-level barriers may also limit or encourage engagement. The goal of this proposal is to conduct methodological studies on the measurement of the neighborhood environments using existing governmental databases and street audits of the men enrolled in the Power-Up diabetes prevention trial.